IGF::OT::IGF SUPPORT SERVICES FOR RADIATION CANCER RISK. 09/19/2016- 09/18/2017. TASK ORDER 7 - REB CORE SUPPORT SERVICES. HHSN261201400010I, CAN# SEVERAL

This is for REB Core Support Services, which consists of the provision of broad-based, centralized, and fully integrated operational, administrative, regulatory, and logistical support services to all REB studies. There are five major sections to these services: 1. Project Management of Ongoing Studies 2. Radiation Dosimetry Work of Ongoing Studies 3. Specimen Collection with Samples 4. Data Preparation and Processing 5. Pilot/Feasibility Studies.